Regulation of arousability by signaling from the gut

Project Summary
Sensory information is always present in the environment but animals can flexibly filter
much of it out. During sleep, the threshold for sensory arousal is increased so that only
stimuli of sufficient magnitude can cross it. In fact, elevating arousal threshold is essential
for being able to sleep deeply, which is essential for the normal restorative function of
sleep. The mechanisms that control arousability are largely mysterious, but they must
integrate sensory information with information about internal physiology. Nutritional status
is a major determinant of arousability – hungry animals often stay awake and forage; if
asleep, they are easily arousable. While some progress has been made in understanding
how nutrients regulate sleep duration (quantity), there is almost no understanding when
it comes to their influence on sleep depth (quality).
We discovered a gut-to-brain signaling pathway that uses information about ingested
nutrients to control arousability from sleep, and consequently sleep depth, without
affecting sleep duration. Protein ingestion causes endocrine cells in the Drosophila gut to
produce more CCHa1, a peptide that decreases sensory responsiveness. CCHa1 is
received by a small group of brain dopaminergic neurons whose activity gates behavioral
responsiveness to mechanical stimulation. These dopaminergic neurons innervate the
mushroom body, a brain structure that is also involved in determining sleep duration – at
a compact point in the brain, the streams of information relevant for sleep quantity and
quality converge. This affords an opportunity to study the regulation of sleep quantity and
quality separately, but also to understand how these parameters are integrated.
Here we propose to characterize the CCHa1 pathway in more detail. We will ask how, on
a molecular level, dietary proteins are sensed in the gut and how this information is
converted into changed activity of dopamine neurons in the brain. We will also investigate
the impact of sleep quality on health and longevity across lifetime.

Public health relevance
Project Narrative It is estimated that around 70 million Americans chronically suffer from poor sleep, not only spending insufficient time sleeping but also not sleeping deeply enough. Deep sleep depends on the ability to stop perceiving the world that surrounds us, a little- understood phenomenon. We found that a signal from the gut can help the brain disconnect disconnect to such a large degree, and propose to study this regulation further, with the ultimate goal of developing strategies for improving sleep quality.